Transcriptional inactivation of the CNS HIV reservoir with Tat-targeting lipid nanoparticles.

Project Summary:
Despite the success of antiretroviral therapy (ART), HIV remains an incurable infection, due to the presence of
a persistent viral reservoir that is resistant to ART. This reservoir is widely disseminated throughout the body,
including in solid tissues such as the central nervous system (CNS) where microglial cells constitute the
primary reservoir. New cure approaches are needed that promote permanent silencing or inactivation of viral
gene expression. In particular, the viral protein Tat plays a central role in driving viral gene expression, and
secretion of Tat from infected microglia likely contributes to CNS toxicity and HIV-associated neurocognitive
disorder (HAND). Thus, irreversibly inhibiting or inactivating Tat in brain resident microglia could represent an
effective way to block viral reactivation and to limit virus-induced HAND. However, no antiviral drugs that
target Tat or viral transcription are currently available for clinical use. In this proposal we aim to develop
microglia-targeting lipid nanoparticles (LNPs) containing Cas9/sgRNA complexes that inactivate the viral Tat
gene, leading to loss of Tat expression and permanent silencing of HIV proviruses. In a key breakthrough, we
have recently identified a novel LNP formulation (MG-LNP) that is optimized for biomolecule delivery to
microglia and we have demonstrated successful use of this formulation for CNS gene targeting in mice. MG-
LNPs containing Cas9/sgRNAs against Tat will first be optimized in microglial models of HIV infection (Aim 1),
followed by testing in ex vivo brain samples from SIV infected macaques (Aim 2). Finally, we will use a novel
humanized mouse model of HIV CNS/microglia infection to test this approach in vivo, in the presence or
absence of cannabinoid exposure (Aim 3). If successful, these tools will prevent the microglial reservoir from
reactivating after therapy interruption and will also mitigate residual CNS pathogenesis from Tat expression
during therapy.

Public health relevance
Project Narrative: Despite the success of antiretroviral therapy (ART), HIV remains an incurable infection, due to the presence of a persistent viral reservoir that is resistant to ART. In this proposal we aim to develop microglia-targeting lipid nanoparticles (LNPs) containing Cas9/sgRNAs that inactivate the viral Tat gene, leading to loss of Tat expression and permanent silencing of HIV proviruses. If successful, these tools will prevent the microglial reservoir from reactivating after therapy interruption and will also mitigate residual CNS pathogenesis from Tat expression during therapy.